Forcing the sinoatrial node pacemaker function

PROJECT SUMMARY
Pacemaking sinoatrial node (SAN) that orchestrates the heart rhythm can become dysfunctional with aging.
Biopacemakers composed of human induced pluripotent stem cell (hiPSC)-derived pacemaking cardiomyocytes
(P-CMs) can be one therapeutic strategy that can restore the sinus rhythm in patients suffering from SAN
dysfunction. The development of biopacemakers is hampered by issues such as low differentiation yield of P-
CMs from hiPSCs and the long-term maintenance of the pacemaking function in engineered pacemaking tissues.
The function and phenotype of P-CMs can be affected by mechanical forces imposed by the extracellular matrix
(ECM) forming the cellular microenvironment and the cyclic strain due to cardiac contractions. The ECM has
been well demonstrated for shaping the phenotype of the working CMs. Hence, an optimal ECM should also
promote and sustain pacemaking function in P-CMs. We have data demonstrating that ECM of the SAN can
better sustain the pacemaking phenotype in hiPSC-derived CMs even when subjected to cyclic strain compared
to the left ventricular counterpart but the exact mechanisms that induce and maintain the pacemaking phenotype
are unclear. The goal of this project is to understand the mechanisms of mechanotransduction in P-CMs that
can be modulated by the ECM. We hypothesize that the SAN ECM may modulate the mechanotransduction in
resident P-CMs via cell-ECM junctions at the costameres and the cell-cell junctions at the fascia adherens to
maintain the pacemaking phenotype. To test the mechanistic underpinnings of our hypothesis, we propose the
following three aims: 1) to determine the cell-ECM-mediated mechanotransduction signaling in P-CMs, 2) to
determine the cell-cell-mediated mechanotransduction signaling in the P-CMs, and 3) to determine the integrated
cell-ECM and cell-cell junction network in mechanotransduction signaling in the P-CMs. A better understanding
of the mechanotransduction mechanisms in P-CMs can yield a source of human P-CMs from hiPSCs with long-
term pacemaking function, a set of microenvironmental criteria necessary for engineering sustainable
biopacemakers and inspire future new therapeutic or preventive strategies for SAN dysfunction.

Public health relevance
PROJECT NARRATIVE Sinoatrial node dysfunction that affects one in 600 people over 65 years of age is mainly treated by an implantable pacemaker to restore the sinus rhythm; however, electronic devices have inherently insurmountable design limitations. The goal of this proposal is to understand how the microenvironment and imposed forces affect the pacemaking function in pacemaking cells differentiated from human induced pluripotent stem cells (hiPSCs). Findings form this study can generate a sustainable source of pacemaking cells for engineering biopacemakers that circumvent limitations associated with electronics and inspire new therapeutic strategies or preventive measures for sinoatrial node dysfunction.